Elucidating the role of mRNA m6A methylation in tumorigenesis

PROJECT SUMMARY/ABSTRACT
The current lack of effective, targeted cancer therapies reflects a gap in knowledge surrounding the
mechanisms that promote tumorigenesis and emphasizes the need for new therapeutic approaches. For
decades, genetic drivers were thought to be the sole mechanism that promote tumorigenesis. Recent
advances have established epitranscriptomics, which details the regulatory and functional roles of RNA
modifications, as an emerging mechanism of tumorigenesis and potential therapeutic avenue. N6-
methyladenosine (m6A) is the most prevalent modification on messenger RNA (mRNA) and serves key roles in
gene regulation and expression. However, our understanding of how mRNA m6A methylation contributes to
tumorigenesis is limited and warrants further investigation. The F99 phase of my proposal will determine the
novel role of ALKBH1, a member of the AlkB family of Fe2+/𝛼𝛼-ketoglutarate-dependent dioxygenases, in
regulating mRNA m6A methylation in arsenic-induced skin tumorigenicity. Chronic exposure to inorganic
arsenic through contaminated drinking water is a major carcinogenic driver of skin cancer. However, the
mechanisms that underlie arsenic-induced skin tumorigenicity remain poorly understood and few therapeutic
targets have been identified. I hypothesize that ALKBH1 promotes arsenic-induced skin tumorigenesis by
demethylating m6A on mRNA and regulating gene expression post-transcriptionally. The F99 phase of this
proposal will address critical gaps in knowledge surrounding the molecular mechanisms that underlie arsenic-
induced skin tumorigenicity and establish ALKBH1 and/or its targets as therapeutic targets for arsenic-induced
skin cancer. The K00 phase will address a broader question and profile the dynamic role of m6A methylation in
malignant transformation. Malignant transformation is a dynamic process. However, our understanding of the
mechanisms that drive malignant transformation is limited to static comparisons across non-transformed and
transformed cells and the transitional states that mediate the transformation between these cell types remain
uncharacterized. The K00 phase will address this gap in knowledge by using m6A-sequencing to longitudinally
profile the m6A-dependent epitranscriptome using validated models of in vitro transformation across a panel of
carcinomas. I hypothesize that the m6A-dependent epitranscriptome changes dynamically throughout
malignant transformation and that I will identify novel m6A-dependent targets that will increase our
understanding of the processes that underlie the transformation from a normal cell to a tumorigenic cell.
Successful completion of the F99 and K00 phases of this proposal will establish novel mechanisms of m6A
regulation and function and identify new therapeutic targets and potential biomarkers of cancer development.
My ultimate career goal is to become an independent investigator and run an interdisciplinary lab conducting
NIH-funded work that investigates the interplay between epitranscriptomics and cancer.

Public health relevance
PROJECT NARRATIVE Epitranscriptomics, which details the functional and regulatory roles of RNA modifications, is an emerging mechanism of tumorigenesis and further studies into this field may unveil potential novel, druggable targets that will lead to the development of more effective cancer therapies. The F99 phase of this proposal will establish the mechanism by which ALKBH1 regulates mRNA m6A methylation and arsenic-induced skin tumorigenicity and may characterize ALKBH1 and/or its targets as therapeutic targets for arsenic-induced skin cancer. The K00 phase of this proposal will profile the dynamic role of m6A methylation throughout the process of malignant transformation and will identify novel m6A-dependent therapeutic targets or biomarkers that underlie the transition from non-transformed cell to transformed, tumorigenic cell.